Core C - Biostatistics & Bioinformatics Core

PROJECT SUMMARY
The Biostatistics and Bioinformatics Core (Core C) of the NYU Melanoma SPORE will provide statistical and
bioinformatics collaboration and consultation to all SPORE Research Projects and Cores. Consultation is
available from the study design and planning stages through implementation, data management, statistical and
bioinformatics analysis, and interpretation of results. Core C will provide support for all proposed laboratory
studies and translational studies, including biomarker development based on samples from existing and new
clinical trials to support the overarching mission and central scientific strategy of the NYU Melanoma SPORE.
Furthermore, strategies for the systematic selection of samples from all the projects and the coordination of
informatics support in Core C will permit the overall integration of results across projects to develop
comprehensive models to predict treatment outcomes and toxicity. Core C draws on and integrates an extensive
fund of knowledge, resources, and expertise across the NYU Langone Medical Center (NYULMC) and NYU
Perlmutter Cancer Center (PCC) to serve the NYU Melanoma SPORE. Co-Director Dr. Yongzhao Shao is
Deputy Director of the PCC Biostatistics Shared Resource (BSR) and Dr. Itai Yanai is the Director of the Institute
for Computational Medicine, respectively, and will provide integrated biostatistical and bioinformatics support
and ensure maximum utilization of all institutional resources and facilities. This will empower the provision of
expertise in all aspects of statistical design; power/sample size calculations; systematic sample selection
strategies for efficient data integration and analyses; and integration of data from multiple sources including
laboratory data, clinical data, and data from diverse sequencing platforms. Core C will develop innovative
statistical and bioinformatics methods, including scalable computation algorithms, for identifying and evaluating
biomarkers in translational studies, and will make these newly developed algorithms publicly available to the
larger cancer research community. In particular, Core C’s identification of biomarkers that may optimize the
personalized management of advanced melanoma patients will enable the development of integrated,
multivariable predictive models for treatment response and toxicity. This work, based on biomarkers discovered
across SPORE Projects, will contribute to personalized melanoma management and amplify the translational
impact of the NYU Melanoma SPORE.

Public health relevance
PROJECT NARRATIVE The Biostatistics and Bioinformatics Core (Core C) provides statistical and bioinformatics collaboration and consultation to all NYU Melanoma SPORE Research Projects and Cores and develops new methods for data analysis when needed. Its development of innovative statistical designs and analytical and informatics methods will facilitate the development of integrated biomarker models for predicting treatment response and toxicity that can directly contribute to personalized medicine and impact melanoma patient care.